VIRALGEN VECTOR CORE SL:1516908 [25-000265]

NCATS requires stability data and related
documentation that demonstrates stability and chain of custody of a cGMP MMA-101
gene therapy product.
Viralgen Inc. manufactured MMA-101, a
gene therapy product, to meet current good manufacturing practices (cGMP) for Selecta
Biosciences Inc under contract to support a Selecta-sponsored clinical trial at the NIH
Clinical Center. Selecta was the collaborator of NHGRI, who developed MMA-101. In
2023, Selecta withdrew the FDA-approved Investigatory New Drug (IND) appplication,
after opening the MMA-101 study at the NIH Clinical Center, and then merged with
Cartesian Inc. towards the end of 2023. At that point, Selecta/Cartesian donated the
cGMP MMA-101 gene therapy product along with its rights and IND documentation to
NIH/NHGRI, enabling the MMA-101 product to be tested in MMA patients.
The objective of this purchase is to acquire the stability data and related documentation
produced and owned by Viralgen in order to demonstrate the stability and chain-ofcustody
for the MMA-101 cGMP material, to ensure it has not been compromised and
can be tested in a clinical trial at NIH.
Rare Diseases